Activity-based protein profiling of the human rhomboid proteases for inhibitor discovery and enzyme characterization

It has been estimated that there could be more than one million different protein species in the human body. Our
understanding of the biological roles of these various species is still limited to a small subset of proteins.
Hydrolases, proteins that cleave chemical bonds using water, represent one of the largest classes of enzymes
in the human body and play essential roles in numerous physiological pathways ranging from metabolism to
nervous system signaling. Despite the prevalence and importance of this enzyme class, the biological functions
of many hydrolases are still not well-characterized. Among the hydrolases with limited characterization, rhomboid
proteases, which perform hydrolysis chemistry within the hydrophobic environment of biological membranes,
have generated notable interest. Mutation and dysregulation of these enzymes in neurodegenerative diseases
and multiple types of cancer motivates the development of an enhanced understanding of their physiological
roles and an investigation of their potential to serve as therapeutic targets; however, methods to conduct these
studies are currently lacking. Activity-based protein profiling (ABPP) technology, in which active site-directed
chemical probes are used to detect enzyme activity, has facilitated the characterization of dozens of serine
hydrolases. As members of this superfamily of enzymes, the human rhomboid proteases (RHBDL1, RHBDL2,
RHBDL3, RHBDL4, PARL) represent promising candidates for study by ABPP methods, though suitable probes
are needed to perform these studies. This proposal aims to (1) convert previously disclosed rhomboid protease
inhibitors into new activity-based probes for the rhomboid proteases and other serine hydrolases, (2) develop an
optimized b-lactone probe to establish a robust ABPP assay to study inhibition and proteolytic processing of
RHBDL2, and (3) study the potential influence of the large aqueous-exposed N-terminal domains of RHBDL1
and RHBDL3 on the activity of these enzymes. These studies will empower ongoing efforts to investigate the
biological roles of the human rhomboid proteases and, ultimately, their potential to serve as therapeutic targets.
Importantly, the proposed project will provide an opportunity to train Oberlin undergraduate researchers in
contemporary chemical biology methods that incorporate techniques from synthetic chemistry, biochemistry, and
molecular biology. Research students at Oberlin will learn theory and advanced laboratory skills not otherwise
covered in an undergraduate classroom or teaching laboratory setting while also further developing their ability
to analyze and present scientific data. Collectively, these activities will enrich the research environment at Oberlin
College and help prepare the next generation of researchers in interdisciplinary molecular science.

Public health relevance
Hydrolases, enzymes that cleave chemical bonds using water, are involved in numerous physiological processes ranging from metabolism to nervous system signaling, but the biological functions of many hydrolases remain unknown. Though still not fully characterized, rhomboid proteases have generated notable interest due to their unique biochemistry and their increased levels in multiple types of cancer. This proposal aims to (1) develop chemical probes to study the enzymatic activities of the human rhomboid proteases, (2) characterize the broader reactivity of compounds that inhibit these enzymes, and (3) understand the structural features of these enzymes essential for their functions.